TENIDAP VS NAPROXEN EFFECTS ON BONE MINERAL DENSITY IN RHEUMATOID ARTHRITIS

To test whether tenidap is more effective than naproxen in stablizing loss of bone mineral and joint damage in patient with rheumatoid arthritis